Neuroresilience to hyper-gravity and desiccation in tardigrade Hypsibius exemplaris

SUMMARY: The stability of neural connections (synapses) and long-term survival of neurons are critically
important to human health, as many neurological and neurodegenerative disorders, including dementia, result
in the loss of vital synaptic connections in the brain. These dementia disorders currently affect 28 million people
worldwide, a number that will increase precipitously as our population continues to age. The proposed research
will explore how synapses are maintained when faced with exposure to extreme environmental stressors with
the aim of identifying translatable molecular targets to prevent synaptic loss during the normal aging process
and the diseased state. To evaluate synaptic stability in the extremes, we will use an invertebrate species, the
tardigrade Hypsibius exemplaris, which has the ability to survive near-complete desiccation, and which I
recently found can survive extreme hyper-gravity equivalent to 500,000 times the earth’s gravity for an hour.
Mechanisms by which the animal survives desiccation are relatively well understood, in that the animal forms
a ‘tun,’ an inanimate state of metabolic suspension which is accompanied by gross morphological changes
and the loss of nearly 99% of their water content. In contrast, the mechanisms by which these animals survive
the extreme forces exerted by hyper-gravity remain wholly unexplored. Following reanimation from desiccation
or return to normal gravity, animals rapidly restore coordinated walking and head motions suggesting that their
nervous system remains grossly unperturbed by these phenomenal feats of extremotolerance. A critical
question is how the nervous system and synaptic function remain stable under these extraordinary
environmentally induced stresses. The proposed research will unveil the underpinnings of tardigrade nervous
system survival by testing the hypothesis that tardigrades fortify their nervous system through the stabilization
of synapses under extreme environmental insults. We will first explore anatomical changes to synapse density
and morphology during desiccation and hyper-gravity by direct visualization of synapses and neurons in the
nervous system (Aim 1). We will assess the functional maintenance of synapses throughout desiccation and
hyper-gravity via a memory-retention paradigm (Aim 2). Finally, we will identify novel targets by monitoring the
dynamic changes in the “proteome” that are triggered by extreme hyper-gravity and desiccation, analyze the
functional roles of synaptic proteins via the removal of key synaptic regulatory proteins and ultimately apply
our identified target molecules to analysis of an in vitro mouse model of neurodegeneration (Aim 3).

Public health relevance
PROJECT NARRATIVE: Neurodegenerative Disorders, such as Alzheimer's Disease and other dementias, as well as the general aging process, are characterized the distinct loss of vital synaptic connections in the brain21; as of 2019, diseases such as this affect a devastating 57.4-million people worldwide22. The proposed research seeks to break the mold of conventional research on Neurodegeneration, exploring a unique phylum of invertebrates, the tardigrade, whose entire nervous system can survive extreme environmental stressors without observable impact on nervous system function. Our work will unveil and subsequently assess the utility of novel homologous targets for a therapeutic generation with the potential to revolutionize our understanding of the limits of fundamental animal physiology as well as neurodegenerative patient outcomes.